Geometric contributions to the morphogenesis of tissues into correct organ shapes

Project Summary
A daunting aspect of development is the orchestration of precise organ formation, guided by the transformative
process of tissue morphogenesis. Errors in this process result in congenital malformations, for which
treatments by tissue reconstruction and organ engineering are only as effective as our understanding of tissue
development in vivo. Our current view of morphogenesis is anchored in the roles of developmental genes, but
we have come to understand that the spatial context where a gene functions also matters. This is governed by
tissue material properties and geometry. Recent significant progress has revealed the in vivo functions of
material properties. The geometry of a developing tissue has historically eluded functional in vivo research due
to a lack of direct tests, though intuitively tissue geometry likely constrains and feeds back on genetics and
material properties in vivo. With the zebrafish embryonic inner ear as a model system, I will directly tune
geometry to uncover how geometry regulates morphogenesis.
In this proposed study I will investigate how geometry contributes to tissue morphogenesis in the zebrafish
inner ear. In Aim 1, I will explore how the geometry of stress distributed across the tissue impacts the resulting
tissue shape. I will first infer cell stress by fitting a model with tissue-wide strain rates calculated from changes
in 3D cell shapes. I will then map inferred stress distribution with higher resolution using transcriptional identities
revealed through spatial transcriptomics. This will be a novel application of spatial transcriptomics across time
in a developing tissue and will also reveal the stress-fate relationship on a tissue-wide scale over time. Finally,
I will then test how geometric distribution of stress regulates morphogenesis through perturbation of tissue-
wide stress distribution. In Aim 2, I will study how the initial geometry of the tissue itself contributes to successful
morphogenesis. I will first quantify changes in morphology and surface curvature during healthy inner ear
development. This will inform a physical vertex model of the tissue’s surface, with which I will make predictions
about tissue geometry’s contributions to morphogenesis. Finally, I will directly perturb initial tissue geometry
and measure how this impacts the progression of morphogenesis and the resulting organ shape. These
perturbations will test the biophysical accuracy of my surface vertex model, highlighting features that
recapitulate development, from which we will learn and build our intuition of the system. The results of
perturbations from both aims will independently reveal in vivo functions of geometry in morphogenesis.
Successful completion of this study will uncover fundamental aspects of inner ear development, informing
disease etiology of congenital syndromes, particularly those that exhibit inner ear, renal, and cardiovascular
comorbidities. By quantitatively investigating geometry’s contributions to morphogenesis in vivo, my proposed
work will uncover specific geometric parameters that influence proper organ shape, which will move the field
of tissue engineering forward in exciting and transformative ways.

Public health relevance
Project Narrative Organ structures, vital for function, are sculpted inside developing embryos within specific geometric contexts, but the function of this spatial context, the geometry of developing tissues, in proper organ shaping has yet to be shown in an animal. Using the developing zebrafish inner ear as a model, this proposal will test how tissue geometry regulates tissue morphology and stress distribution to guide organ shapes during development. The results of this proposed study will fundamentally improve tissue engineering design for therapeutic tissue reconstruction and replacement.